BIOSTATISTICS AND DATA MANAGEMENT SECTION

The Section is the statistical and data management component of the Clinical Oncology Program (COP). The Section provides statistical leadership and data management consultation for major activities of the Program, and is involved in the design, conduct, monitoring, and statistical analyses of intramural and national multicenter clinical trials of experimental treatments for cancer. Other major collaborative efforts include studies to identify important prognostic and treatment selection factors, evaluate diagnostic procedures, develop improved staging systems, and assist investigators in the design, execution, and analyses of major in vitro drug testing studies. The Section develops new statistical designs and biometric methods related to the development and evaluation of new cancer treatments. The Section maintains computerized data collection systems for intramural and national multicenter clinical protocols, and it works closely with interested branches to improve data recording and retrieval. The Section is working to develop specialized clinical databases for individual branches within the COP. The Section works with the Clinical Center Medical Information System team, allowing COP input into decisions which directly impact patient care and protocol management. The Section assists the Deputy Clinical Director to insure adequate monitoring of protocols through the MIS Toxicity screens and other mechanisms.